Path C Advancement of the Produce Safety Rule by the South Carolina Department of Agriculture through the FDA's Cooperative Agreement Program for Produce Safety, Path C

South Carolina Department of Agriculture
Consumer Protection Division
123 Ballard Court, West Columbia, SC 29172
Hugh E. Weathers, Commissioner
Project Summary
Project Name: Advancement of the Produce Safety Rule by the South Carolina
Department of Agriculture through the FDA’s Cooperative Agreement Program for
Produce Safety, Path C
Funding Opportunity Announcement Number: PAR-21-174
Principal Investigator Produce Safety Manager
Elizabeth “Betsy” Dorton Kelly Johnson
Office #: (803) 734-0467 Office #: (803) 753-7267
Email: [email] Cell#: (843) 845-7707
Email: [email]
The South Carolina Department of Agriculture (SCDA) is dedicated to further advancing
their efforts of educating and regulating South Carolina produce farms on the Produce
Safety Rule through Path C of the cooperative agreement (FOA #PAR-21-174). Our
produce safety program operates under state authority. Our state law is known as the
South Carolina Produce Safety Act. This law gives the South Carolina Department of
Agriculture the authority to inspect and enforce the Produce Safety Rule (21 CFR 112)
in its entirety in South Carolina.
The SC Produce Safety Act can be found at:
https://www.scstatehouse.gov/code/t39c026.php

Public health relevance
South Carolina Department of Agriculture Consumer Protection Division 123 Ballard Court, West Columbia, SC 29172 Hugh E. Weathers, Commissioner Project Narrative Project Name: Advancement of the Produce Safety Rule by the South Carolina Department of Agriculture through the FDA’s Cooperative Agreement Program for Produce Safety, Path C Funding Opportunity Announcement Number: PAR-21-174 Principal Investigator Produce Safety Manager Elizabeth “Betsy” Dorton Kelly Johnson Office #: (803) 734-0467 Office #: (803) 753-7267 Email: [email] Cell#: (843) 845-7707 Email: [email] The South Carolina Department of Agriculture (SCDA) is dedicated to further advancing their efforts of educating and regulating South Carolina produce farms on the Produce Safety Rule. Through education, outreach, inspections, compliance and enforcement our mission of this 5-year project is to reduce foodborne illnesses by enhancing the safety in growing, harvesting, packing, and storing fresh fruits and vegetables.